Von Willebrand Factor Hyperactivity, Angiogenesis and LVAD-Induced Bleeding

Project Summary
Left ventricular assist device (LVAD) provides cardiac support for patients with end stage heart disease and
has significantly improved the survival of these patients, but device-related bleeding remains common and are
associated with poor clinical outcomes. Even latest (3rd) generation devices have been able to significant
impact device thrombosis (e.g.MOMENTUM3 trial), however with some surprise they have not been able to
resolve LVAD related bleeding which remains a significant source of morbidity and complicates clinical
management, ultimately leading to poor clinical outcomes. The LVAD-associated bleeding is often called
acquired von Willebrand syndrome (aVWS) that is believed to be caused by excessive cleavage of VWF
multimers by ADAMTS-13. However, this tentative mechanism has not been experimentally validated and
significant gaps remain. The loss of large VWF multimers is observed in nearly all patients, but only a fraction
of patients experience significant bleeding. High shear stress is known to promote VWF cleavage and
activation to bind platelets, but this shear-induced VWF activation has not been studied in patients on LVAD.
We hypothesize that: 1) Plasma VWF multimers in LVAD patients are subjected to higher rates of cleavage
and activation than healthy subjects and patients with end stage heart disease prior to LVAD implant 2) LVAD-
induced high shear stress results in VWF dysfunctions responsible for impaired hemostasis and triggers
downstream VWF mediated angiogenesis 3) These shear-induced structural changes of VWF can be detected
in patients on LVAD and can predict bleeding propensity developed after LVAD implantation. We propose to
test these hypotheses with three specific aims. First, develop predictive markers for LVAD-induced hemostatic
complications by comprehensively analyzing the imbalance between VWF activity and cleavage in longitudinal
plasma samples from 240 patients collected before and after LVAD implantation using flow cytometry, mass
spectrometry, microfluidic chamber systems, and conventional VWF functional tests. Second, study shear-
induced structural changes of the VWF A1 and A2 domains and their roles in regulating rates of VWF cleavage
and activation using in vitro techniques and mouse models. Third study how VWF synergizes with extracellular
vesicles to promote immature angiogenesis, which leads to bleeding-prone arteriovenous malformation. The
objectives of this mechanistic study are to: 1) define shear-induced structural changes of VWF using state-of-
art biophysical techniques and study how these changes influence VWF cleavage and activity, 2) study how
high shear stress disrupts the inhibitory interaction between the A1 and A2 domains to alter the A1 interface
with the platelet VWF receptor GP Ib and to unfold A2 for cleavage, and 3) investigate the role of VWF in
angiogenesis. We have assembled a team of experts in related clinical and research fields from 3 institutions
to conduct this innovative research focused on improving LVAD outcomes and provide insight on how aVWS
may play a role in surgical and percutaneous continuous flow devices.

Public health relevance
Project Narrative The proposed study is designed to understand the mechanism of LVAD-associated bleeding complications using the state-of-art biophysical and mass spectrometry technologies, and conventional clinical tests. The study objectives are to 1) develop new model to predict for LVAD- induced bleeding 2) investigate the structural changes of the adhesive protein VWF induced by high shear stress found in the LVAD-derived blood flow, and 3) to study how cellular fragments and VWF promote the formation of immature blood vessels.